Intraoperative stereo imaging for oral specimen orientation and margin visualization

ABSTRACT
Management of positive surgical margins in the resection of oropharyngeal squamous cell carcinoma (OPSCC)
is an imprecise science, yet its results drastically affect patient outcomes. New cancers of the oral cavity and
pharynx are diagnosed at 11.4 cases per 100,000 Americans annually, with incidence rising steadily due to HPV-
mediated disease. Most patients with early-stage OPSCC are treated surgically; however, positive surgical
margins (PSMs) complicate approximately 30% of traditional and 15% of robot-assisted procedures. Re-
localization of positive margins is important for both intraoperative management with frozen section guidance,
and for postoperative planning of adjuvant radiation therapy. In both cases, inaccurate orientation and
localization can lead to incomplete treatment and excessive iatrogenic damage to healthy tissue, resulting in
reduced local control and overall survival. We propose a novel, robot-integrated system for intraoperative
creation and annotation of digital 3D models of resection specimens and the residual tumor bed. These models
will employ visual feature correspondences to warp between the shape of the flattened specimen and the in situ
oropharyngeal anatomy. As such, positive margins identified intraoperatively by frozen section or postoperatively
by permanent section can be accurately mapped to the specimen and also to the in situ anatomy. We
hypothesize that this digital pathology solution will integrate seamlessly into the transoral-robotic surgery (TORS)
workflow and provide the care team with qualitative and quantitative margin localization data that will 1) improve
clinical communication around specimen orientation and margin context, and 2) enable more precise, patient-
specific adjuvant therapies, ultimately reducing recurrence and improving overall survival. In Aim 1, we will
develop 1) the necessary workflow from stereovision to 3D specimen models, 2) in-console annotation
functionality, and 3) model deformation capabilities. In Aim 2, we will conduct a single-site human subjects
feasibility and effectiveness evaluation. At the end of the performance period, we will deliver a robust, robot-
integrated specimen orientation and margin visualization system ready for implementation in a multi-site
prospective study designed to quantify the effects of the proposed system on local control and survival in TORS.

Public health relevance
PROJECT NARRATIVE Surgery for head and neck cancer is challenging, and 15-30% of patients leave the operating room with some tumor remaining. Many of these procedures are already performed using advanced robotic technology that we believe can be leveraged to provide surgeons, pathologists, and radiation oncologists with accurate 3D maps of the remaining cancer. This additional information will help clinicians better target additional surgery or radiation therapy, ultimately reducing the risk of recurrence and improving overall survival.